Using Natural Language Processing and Speech Processing Techniques to Understand and Predict Cognitive Decline

Abstract
Alzheimer’s disease and related dementias are a significant public health concern, especially for disaster
responders and construction workers exposed to neurotoxic hazards. Although valuable data about
occupational exposure and cognitive health can be obtained from open-ended questions, analyzing such
unstructured text and audio data is often time-consuming and underutilized. Recent advancements in Natural
Language Processing (NLP) and Speech Processing (SP) offer new opportunities to efficiently extract this
information and predict cognitive outcomes.
This proposal aims to leverage NLP and SP tools to analyze unstructured free text and audio data from the
World Trade Center (WTC) responder cohort, a population at high risk for cognitive decline due to disaster-
related neurotoxic exposures. I developed and validated a linguistic tool (NLP method) to extract occupational
exposure variables—termed "WTC Exposure to Response Activities (WERA)"—from free text descriptions of
work activities. In the F99 phase, these WERA variables will be used to predict mild cognitive impairment (MCI)
incidence, cognitive trajectory, and neurodegenerative biomarker distributions, with mask usage as a potential
mediator. This NLP method will advance research in occupational cognition health by reducing reliance on
structured lists and manual categorization of occupational activity exposures.
In the K00 phase, I will expand the research by utilizing advanced NLP and SP techniques to analyze interview
transcripts and audio recordings. By extracting both linguistic and acoustic features—such as word-finding
difficulties, reduced vocabulary, pitch, pauses, and vocal quality—through pre-trained models like RoBERTa
and Wav2Vec, I aim to predict future cognitive changes in domain-specific cognitive functions. These features
will be processed using machine learning models (e.g., random forest regressor, support vector regression,
and neural networks) to predict cognitive decline over time. This approach offers a non-invasive, scalable, and
cost-effective method for early detection of cognitive impairment, potentially benefiting other at-risk
populations, including veterans and older adults exposed to neurotoxic hazards.

Public health relevance
Narrative This proposal focuses on developing advanced Natural Language Processing (NLP) and Speech Processing (SP) tools to analyze unstructured text and audio data from World Trade Center (WTC) responders, a high-risk cohort for cognitive impairment due to neurotoxic exposure during the 9/11 disaster rescue and recovery effort. The NLP tools will extract occupational exposure variables from text description of response activity, correlate them with cognitive outcomes, and examine how surgical mask usage mediates these correlations. The ultimate goal is to use NLP, SP, and machine learning methods to build a predictive model from clinical interview recordings to monitor future cognitive changes.